Understanding cannabidiol policy and its impacts on broader substance use

PROJECT SUMMARY
Substance use in the United States is evolving. Some of these changes are due to the ongoing
opioid crisis while other changes are results of federal and state policy changes. In particular,
marijuana access continues to be further legalized throughout the United States, changing
behaviors related to alcohol and opioid use. While we have developed an adequate research
base on the implications of medical and recreational marijuana laws, researchers have generally
ignored the recent growth in cannabidiol (CBD) access, including the legalization of medical
CBD in 18 states since 2014 that do not otherwise permit medical or recreational marijuana.
CBD access continues to expand in the US with rates of use higher than marijuana, but we have
little evidence of the public health impacts of this expansion.
This project will study these recent laws and discuss how they fit into the broader marijuana
policy landscape in the United States. In addition, we will study how medical CBD adoption
impacts CBD use, opioid use, alcohol use, and opioid- and alcohol-related poisonings.
Marijuana policies has been shown to impact alcohol use; additionally, they have been found to
deter opioid misuse and reduce opioid-related deaths. We hypothesize that CBD policies may
have similar effects. In particular, this project is interested in the possible role for alternative
pain management availability to impact opioid use and curb overdose death rates. These
relationships are important to quantify as CBD use continues to increase. We will also collect
information on CBD dispensary locations, study the demographics of CBD dispensary access,
and examine more granular geographic effects of CBD access. We will make information on
CBD policies and CBD dispensary locations public to promote research in this area.
More recent research on the impacts of medical and recreational marijuana laws often
contradicts earlier findings. One possible reason for these inconsistent results over time is
because the literature ignores recent medical CBD policies. If CBD policies have similar effects
as marijuana policies, then including CBD-adopting states as “comparisons” in a difference-in-
differences framework will bias the estimates in the opposite direction. This project will
conclude by re-analyzing recent findings in the medical and recreational marijuana literature
while accounting for CBD adoption. This analysis has the potential to reconcile these literatures
by accounting for a policy which has been generally ignored.

Public health relevance
PROJECT NARRATIVE Since 2014, eighteen states have enacted medical cannabidiol (CBD) laws without broader marijuana legalization despite limited evidence of the public health impacts of these policies. This project will study how CBD access, through policy changes and dispensary openings, alters opioid use, alcohol use patterns, and poisoning deaths involving alcohol and opioids. We will also reanalyze the broader cannabis literature which has generally ignored the role of CBD policies in a manner that likely substantially biases recent analyses.